The Jackson Laboratory Knockout Mouse Production and Phenotyping Project (JAX KOMP2)

Project Summary The goal of the Knockout Mouse Phenotyping Project (KOMP) is to provide a comprehensive catalog of mammalian gene function obtained through the creation of 8,500 gene knockouts and execution of a systematic, high-throughput phenotyping pipeline. Launched in the fall of 2011, three production/phenotyping centers including JAX were funded and assigned the task of model creation and broad-based phenotyping. The first phase succeeded in generating and phenotyping 2,500 lines. The goals of phase 2 of The Jackson Laboratory (JAX) KOMP program (KOMP2) during the current funding period (8/1/16 – 7/31/21) are to create 1000 knockout (KO) lines of mice and perform high-throughput phenotyping across organ systems using an efficient and broad testing pipeline. On March 11, 2020 the World Health Organization (WHO) declared the outbreak of severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) disease (COVID-19) a world-wide pandemic. A consequence of the pandemic has been a reduction of our available personnel and services needed to reach our original goals. The purpose of this request for a funded extension beyond the current project period is to ensure continuity of well-developed model production pipelines, and to provide an uninterrupted supply of mouse lines for phenotyping. We are requesting the project be extended with funds for 12 months, with a new project period end date of 07/31/2022.

Public health relevance
Relevance to Public Health The Knockout Mouse Phenotyping Program (KOMP2) seeks to create an encyclopedia of gene function for the ~20,000 genes in the mouse and to ultimately create a resource for understanding gene function in humans. The Jackson Laboratory (JAX) will contribute to this goal by efficiently generating knockout lines and sharing functional data for 1,500 mouse genes. The JAX team will enhance the value of these data by linking them with current genetic and biological knowledge, enabling the scientific community to discover the roles of these genes in human health and disease.